Optimizing medium-chain lipids for the treatment of long-chain fatty acid oxidation disorders

Project Abstract
Long-chain fatty acid oxidation disorders (LC-FAODs) are a heterogenous group of disorders characterized by
the inability to break down long-chain fatty acids in the mitochondria for energy. The primary tissues affected are
liver, heart, and muscle. These disorders are identified at birth through newborn screening programs. Treatment
consists of fasting avoidance and replacing long-chain fats in the diet with medium-chain fatty acids (MCFA).
Despite decades of orally dosing patients with MCFA-containing oils, it is not understood how MCFA are
metabolized by liver, muscle, and heart. Further, the rigor of the experimental evidence regarding the therapeutic
efficacy of oral MCFA is low. In mouse models of LC-FAOD, oral MCFA do not improve cardiomyopathy or the
capacity for exercise. Human patients likewise still suffer from muscle symptoms and rhabdomyolysis. In the
current proposal it is postulated that there are two major problems with current MCFA-based therapies. First,
muscle and heart are not equipped to metabolize exogenous MCFA. Second, orally-administered MCFA are
nearly completely absorbed by the liver and do distribute to heart and muscle. It is hypothesized that MCFA
therapy can be optimized to treat cardiomyopathy and rhabdomyolysis through the exploration of alternative
medium-chain lipid species and alternative routes of delivery. The hypothesis is supported by preliminary data
showing that heart and muscle prefer carnitine conjugates of MCFA (MC-carnitines) over free MCFAs, and a
demonstrated improvement in muscle function of LC-FAOD mice upon subcutaneous injection of an MC-
carnitine. This hypothesis will be fully explored in three Specific Aims: 1) Determine the optimal medium-chain
lipid species for liver, heart and muscle; 2) Determine the bioavailability and biodistribution of orally versus
subcutaneously-administered medium-chain lipids; and 3) Determine the therapeutic efficacy of medium-chain
lipids in LC-FAOD mice. Aim 1 is expected to show that liver prefers free MCFA as substrates, while muscle and
heart prefer MC-carnitines. The differential preference is proposed to be due to the presence of mitochondrial
medium-chain acyl-CoA synthases in liver but not heart or muscle. Aim 2 is expected to demonstrate that
subcutaneous delivery of medium-chain lipids greatly increases bioavailability and subsequent biodistribution to
the periphery. Finally, in Aim 3, pre-clinical testing of LC-FAOD mouse models is expected to document the
therapeutic advantage of the optimized substrates from Aim 1 and the subcutaneous delivery from Aim 2. The
results of this project will lay the groundwork for more personalized, symptom-specific application of MCFA-
based therapies in LC-FAOD patients.

Public health relevance
Project Narrative Long-chain fatty acid oxidation disorders are identified at birth through newborn screening. They are currently treated using medium-chain fatty acids to bypass the enzymatic defects and provide energy, but this therapy is only partially effective in heart and not effective in muscle. The proposed research seeks to optimize the type of medium-chain lipid and the route of administration in order to better treat muscle and heart.